Mechanisms underlying regulation of injured axons in CNS autoimmunity

PROJECT SUMMARY
Developing neuroprotective and repair strategies represents an urgent unmet need for treating
inflammatory demyelinating disorders of the central nervous system (CNS) including multiple sclerosis (MS).
Lesions in both MS patients and the MS mouse model, experimental autoimmune encephalomyelitis (EAE),
involve T lymphocyte infiltration and axonal damage. However, interactions between CNS-infiltrating T cells
and central neurons remain poorly understood. 4-Aminopyridine (4-AP) is an FDA-approved drug for the
symptomatic treatment of MS to improve walking speed. Although it is commonly believed that 4-AP blocks
Kv1 (Shaker) voltage-gated K+ (Kv) channels to enhance axonal conduction and suppress immune response,
the mechanisms underlying 4-AP’s actions in treating MS are still not completely clear. Our new results have
provided several lines of compelling evidence that a Kv3 (Shaw) channel, with high 4-AP sensitivity, is
expressed in both CD4+ T cells and CNS neurons, and plays a key role in T cell-induced axonal injury. This
channel regulates T cell activation that is required for EAE induction, shown by our active and passive EAE
results using its global knockout (KO) mice. This notion is further supported by our data from T cell culture,
immunostaining/confocal imaging, flow cytometry, RNAi knockdown, and conditional KO (cKO) mice.
Therefore, based on our new findings, we propose a novel hypothesis that in the development and pathology
of CNS autoimmunity, Kv3 channel is required for the efficient generation of encephalitogenic T cells, whereas
its upregulation in axons aggravates autoimmune-induced injury via aberrant Ca2+ signaling. To test this
original hypothesis, we have created a floxed mouse line for this Kv3 channel to examine the effects of its cell-
type-specific cKOs on EAE. We will use a multidisciplinary approach, including active and passive EAE
models, inducible cKO and transgenic mouse lines, flow cytometry, confocal and transmission electron
microscopy, functional assays, in vivo RNAi, and a new myelin coculture. We will determine (Aim 1) whether
deleting this Kv3 channel from CD4+ T cells suppresses EAE induction and progression via impaired T cell
activation, (Aim 2) whether deleting this channel from CNS neurons ameliorates autoimmune-induced axonal
injury, and (Aim 3) how this channel regulates pathogenic interactions between T cells and axons in
autoimmune-induced injury. This project is innovative because this is the first study to show that a Kv channel
regulates the function of both immune cells and neurons. This project is significant because the findings of this
project will provide novel mechanistic insights into pathogenic interactions between T cells and neurons, and
hence may contribute to a novel treatment strategy for MS through simultaneously suppressing immune
response and rescuing injured axons.

Public health relevance
PROJECT NARRATIVE This project is to determine the novel role of one type of voltage-gated ion channel in the simultaneous regulation of immune and neural functions in autoimmune-induced injury of the central nervous system. The findings may contribute to the development of a new strategy for treating multiple sclerosis and other autoimmune diseases.